CELL AND MOLECULAR BIOLOGY OF GLOMERULAR CELLS DERIVED FROM TRANSGENIC MICE

omeruli of transgenic mice developing from eggs microinjected with plasmids ntaining the SV40 early region genes and metallothionins fusion gene will isolated and ex-planted. The individual glomerular cells will be olated, cloned, and brought to confluence. The characteristics of the oned glomerular cells from transgenic and their non-transgenic litter mates ll be studied for their ability to proliferate, their growth in a defined sement membrane matrix, and for their synthesis of extracellular matrix oducts. Their response to various inflammatory mediators will also be vestigated.